Glutamergic Mechanisms in Opioid and Cocaine Co-Use

Opioid use disorder (OUD) is a leading public health crisis in the United States. Individuals with opioid use
disorder frequently use other substances, including cocaine. Past year opioid withdrawal was associated with 4
times greater odds of current cocaine use, which may represent an attempt to ameliorate opioid withdrawal
effects but also increases overdose risk, as evidenced by preclinical and clinical findings. Approved OUD
pharmacotherapies are modestly effective, but these medications are not indicated for treating cocaine co-use,
highlighting the need for a novel intervention approach to improve outcomes in co-morbid OUD and cocaine use
disorder. Mechanistically, drug-motivated behaviors are regulated by glutamate signaling within corticostriatal
circuitry. Both opioid and cocaine self-administration (SA) down-regulate the glial glutamate transporter (GLT-
1), and alter synaptic plasticity measured as changes in dendritic spines and AMPA-to-NMDA current ratios
(A/N) within the nucleus accumbens core (NAcore). Thus, glutamatergic plasticity is a conserved neural
mechanism underlying drug motivation in both opioid and cocaine use. The combined effects of opioid and
cocaine co-use on glutamatergic systems, however, are unknown. n-Acetylcysteine (NAC) has shown
translational promise for treating multiple drug use disorders, including cocaine and opioids. NAC is capable of
restoring glutamatergic alterations induced by either drug alone, likely by increasing glutamate clearance from
the synapse following drug use through upregulation of GLT-1. Clinically, we have shown that NAC reduces the
incentive salience of cocaine-related stimuli, which controls drug seeking. As well, others have shown that NAC
normalizes glutamate function in cocaine-dependent individuals. Whether NAC reduces drug intake and reverses
glutamatergic alterations induced by co-use of opioids and cocaine is unknown. The work proposed here will
begin to fill those crucial knowledge gaps. Our overarching hypotheses are that (1) persistent brain glutamate
changes induced by chronic opioid use will exacerbate use of cocaine during opioid physical dependence and
withdrawal and (2) that NAC will ameliorate glutamatergic dysregulation, and thus will reduce both oxycodone
and cocaine use. We propose a two phase, translational project supported by the R21/R33 mechanism. In the
first phase (R21), we will characterize NAcore glutamatergic signaling in opioid and cocaine co-use as a neural
biomarker for pharmacotherapeutic targeting with NAC using preclinical laboratory methods. Upon meeting the
milestones set forth for the R21, we will conduct the second phase (R33), in which we will determine the influence
of NAC on glutamate function and reinforcing effects of cocaine in co-morbid opioid and cocaine use disorder
using human laboratory methods. The milestones completed during this translational project will elucidate
glutamatergic dysregulation underlying opioid and cocaine co-use, laying the groundwork for effective
pharmacotherapeutic treatment for this pattern of polysubstance abuse through targeting glutamate signaling.

Public health relevance
Project Narrative Problems posed by opioid use disorder are often compounded by comorbid cocaine use. This proposal will use sophisticated preclinical and clinical laboratory models to determine neurobiological mechanisms that contribute to this significant and growing public health concern, and could contribute to the development of novel therapeutic options aimed at reversing opioid and cocaine co-use-induced alterations in the brain.